mHealth-Facilitated Physical Activity Toward Health (mPATH) for Cognitive Function and Sleep in Low-Income Older Adults

PROJECT SUMMARY/ABSTRACT
Low-income older adults (LIOA) are a population at higher risk to develop Alzheimer's disease and related
dementias (ADRD) and sleep disturbances. Although empirical research suggests that physical activity
interventions benefit cognition and sleep in older adults in general, the possible benefit of physical activity is
understudied in LIOA. The available evidence in LIOA suggests that LIOA experience unique barriers to
physical activity, more prevalent physical inactivity and sedentary behaviors. Since physical inactivity and
sedentary behaviors are independent risk factors that have synergistic harmful effects for cognitive function
and sleep, it is crucial to address them simultaneously to promote cognitive and sleep health in LIOA. The
growing wearable device and mobile Health (mHealth) provide an innovative approach to deliver individually
tailored physical activity interventions at home with flexible schedules to overcome barriers to physical activity
in LIOA. In addition, limited research has examined if physical activity interventions impact the individual’s
Amyloid/Tau/ Neurodegeneration (ATN) Alzheimer's disease biological state and whether physical activity may
promote cognition through impacting sleep and AD pathology. This randomized controlled trial is designed to
examine the immediate and sustaining efficacy of an mHealth-facilitated Physical Activity Toward Health
(mPATH) intervention on cognitive function and sleep in LIOA. mPATH is a personalized physical activity
intervention that includes personalized physical activity plans and training sessions, exercise at home by
following personalized exercise videos, and biweekly phone coaching over 24 weeks, supported by wearable
devices-enabled mHealth strategies. mHealth strategies and exercise videos will be used to support
participant’s physical activity during 6-12months. In the proposed study, we will randomize 176 community
dwelling LIOA with insomnia symptoms and without dementia to the mPATH or control group on a 1:1 ratio.
Randomization will be stratified by age, sex, and cognitive status. Specifically, we will (1) test the immediate (6-
month) and sustaining (12-month) effects of mPATH on cognitive function among LIOA, compared to control;
(2) test the immediate (6-month) and sustaining (12-month) effects of mPATH on sleep, compared to control;
and (3) explore the effect of mPATH on ATN biomarkers and potential mediating roles of sleep and ATN
biomarkers in mPATH’s effect on episodic memory.

Public health relevance
PROJECT NARRATIVE This research will provide the first evidence regarding the immediate and sustaining efficacy of an mHealth- facilitated physical activity intervention on cognitive function and sleep in low-income older adults, a population that experiences multiple social inequalities and health disparities and at high risk for Alzheimer’s disease. It will add scientific knowledge on whether physical activity impacts Amyloid/Tau/ Neurodegeneration (ATN) biomarkers and whether sleep and ATN biomarkers underline the effect of physical activity on cognitive function. If successful, the findings will support clinicians and the public to engage low-income older adults in physical activity for better sleep and cognitive health.